The Structure and Function of Ipsilateral Corticospinal Projections

PROJECT SUMMARY
Most corticospinal fibers cross the midline to form the contralateral corticospinal tract (cCST). However,
approximately 10% of them project ipsilaterally to form the ipsilateral corticospinal tract (iCST). The iCST plays
a role in recovery from unilateral stroke or other forms of motor cortical injury by allowing the undamaged cortical
hemisphere to compensate for the damaged one. Despite the clinical importance of the iCST, its naturalistic
function and detailed anatomy are unknown. Individuals recovering from unilateral hemispheric injury experience
erroneous bilateral and symmetrical movements aptly termed “mirror movement disorders.” Transcranial
magnetic stimulation studies have linked the relative strength of the iCST and the severity of these mirror
movements. Furthermore, mutant animals with more robust iCSTs perform bilateral adaptive motor behaviors
more than wild-type animals. This evidence led to the hypothesis that the iCST is involved in the coordination of
bilateral behaviors.
This project uses a combination of viral tracing methods, chemogenetic behavioral experiments, single nucleus
sequencing, and sequencing-based neuronal reconstruction to test the hypothesis that the iCST coordinates
bilateral behavior. In preliminary data, a novel strategy is developed combining monosynaptic anterograde
tracing and single nucleus sequencing to map the postsynaptic targets of the iCST and cCST. Preliminary results
from this method suggested top-down differences in the architecture of the two tracts, with the iCST projecting
more so to interneurons involved in motor control and the cCST more so toward those involved in sensory
modulation. This lead to the hypothesis that the iCST comprises bilaterally-projecting corticospinal neurons.
Such bifurcated neurons would provide a structural justification for the link between the iCST and bilateral motor
behavior: bilateral neurons are naturally well-situated to facilitate bilateral behavior. With MAPSeq, a method of
anterograde viral tracing using molecular barcodes, as well as dual-fluorescence retrograde tracing, preliminary
data indicated that the iCST comprises primarily of bilaterally-projecting neurons. In addition to ensuring these
findings are robust, this project will directly investigate the role of the iCST in motor behavior by using
chemogenetic silencing of the iCST and markerless pose estimation in a well-established behavioral paradigm
of adaptive bilateral movement.

Public health relevance
PROJECT NARRATIVE Roughly 10% of the mammalian corticospinal tract terminates ipsilaterally and is known to be involved in motor recovery from unilateral hemispheric injury; however, its detailed anatomy and function are unknown. The guiding hypothesis of this project is that the ipsilateral corticospinal tract is involved in the coordination of bilateral motor behavior. This project uses a novel method combining single nucleus sequencing and monosynaptic viral tracing to map the connectivity of the iCST at single-neuron resolution, a molecular barcode-based approach to reconstruct its projection structure in detail, retrograde tracing and tissue clearance to map its topography, and chemogenetic tools to investigate its function in behavior.